Defining the autoimmune mechanisms driving human MOG antibody disease pathology

Project Summary. Myelin oligodendrocyte glycoprotein (MOG) antibody disease (MOGAD) is an inflammatory
demyelinating central nervous system condition. MOGAD is a newly defined autoimmune disease that has
clinical phenotypic overlap with multiple sclerosis (MS) and aquaporin 4 (AQP4) autoantibody positive
neuromyelitis optica spectrum disorder (NMOSD), but all three conditions are now recognized as being distinct.
MOGAD is characterized by IgG1 subclass MOG-specific autoantibodies. Patients can present with visual,
motor, ambulatory, bladder, bowel and/or cognitive dysfunction. The mechanisms by which MOG autoantibodies
mediated pathology is not well understood. This is important to understand given the availability of therapeutics
that can target these autoantibody effector functions. In addition, the specific B cell subtypes that express MOG
autoantibodies have not been identified. This additional gap in our knowledge also presents consequences for
MOGAD patient treatment, given that different therapeutic B cell depletion approaches are effective against
distinct B cell subsets.
To address these gaps in our understanding of this disease we will: (i) Generate human monoclonal
MOG autoantibodies from patients; (ii) Use novel approaches to define and measure the different mechanisms
of MOG autoantibody pathogenicity. Specifically focusing on complement-dependent cytotoxicity (CDC) and
antibody-dependent cellular cytotoxicity (ADCC), given that human IgG1 antibodies include these pathogenic
mechanisms, and (iii) Perform deep single cell phenotyping on the specific B cells that express human MOG
autoantibodies.
To accomplish these aims, we have developed a unbiased high-throughput approach for producing MOG-
specific human mAbs by cloning single B cells. This approach will afford production of a diverse MOG-specific
mAb library. New approaches to study the different effector mechanisms of MOG autoantibody pathogenicity
have also been developed. Specifically, we developed high-throughput flow cytometry assays to measure
complement activity (CA), CDC, and ADCC of live cells expressing human MOG. These experiments will define
how the specificity and molecular properties of MOG autoantibodies are associated with pathogenic effector
function. Finally, we will define the phenotypes of autoantibody-producing B cell subsets using high dimensional
flow cytometry and single cell RNA sequencing approaches.
Overall, this investigation will: (i) provide a set of well-characterized human mAbs which will serve as tools for
more accurate modeling of MOGAD pathology; (ii) identify the cellular contributors to autoantibody production
(iii) and importantly for translational value, identify potential new therapeutic avenues for treating MOGAD
through specifically targeting MOG autoantibody effector functions (with complement inhibitors) and/or
production by autoreactive B cells through CD19 or CD20-mediated B cell depletion therapy.

Public health relevance
Project Narrative (relevance to public health) Myelin oligodendrocyte glycoprotein (MOG) antibody disease (MOGAD) is a newly identified syndrome that is characterized by circulating autoantibodies targeting MOG, yet the role of these autoantibodies in disease pathology is not understood. In order to effectively treat patients with MOGAD, we must understand the disease mechanisms, and importantly how they vary from patient to patient. Our investigation aims to define two major contributors to MOGAD pathology, both of which focus only on the specific cells and antibody molecules that make direct contributions to the disease; to that end, we propose to clone disease-causing autoantibodies and cells from patients and test them with a set of assays to define MOG autoantibody- mediated mechanisms, as means to ultimately predict treatment response, monitor disease progression, and enable personalized therapeutic decisions.